Chronic Lower Leg Heating for the Treatment of Hypertension in Older Women

PROJECT SUMMARY
The prevalence of hypertension is greater in older (≥65 years) women than in older men, while the blood
pressure (BP) control rate is lower in older women in the United States. Uncontrolled hypertension is a major
risk factor for cardiovascular morbidity and mortality. Despite standard therapy and adherence to optimal drug
regimens, over 50% of older hypertensive women still have inadequate BP control (e.g. >140/90 mmHg), and
the control rate is further reduced with more aggressive BP targets recommended recently by the new 2017
ACC/AHA Hypertension Guidelines. Thus, the effectiveness of drug treatment alone in the control of
hypertension among older women is limited; hence, non-pharmacological approaches are also needed to help
reduce BP and cardiovascular morbidity and mortality in older hypertensive women. One adjuvant, non-
pharmacological approach that offers promise in lowering BP is “heat therapy”. Indeed, repeated (chronic)
whole-body heat exposure has been found to decrease BP in healthy humans. Whether this is also true after
regional limb heating in hypertensive patients is unknown. The global objectives of this research project
are to investigate the BP lowering effect of home-based lower leg heat therapy in older women with
hypertension, and to examine the impact of this therapeutic modality on neural-vascular health in
these patients. Specific Aim 1 will test the hypothesis that chronic lower leg heat therapy combined with an
antihypertensive drug is superior to drug treatment alone in lowering BP in older hypertensive women. We will
randomly assign older hypertensive women to either an intervention group or a control group. Patients in the
intervention group will perform 8 weeks of home-based lower leg heat therapy via water immersion up to the
knee in a circulated bath (water temperature 42°C, 4 times per week, 45 min per session), whereas patients in
the control group will immerse their legs in a thermoneutral water bath (33°C) at the same frequency and
duration. All patients will also receive a fixed dose of chlorthalidone (a diuretic, 25 mg orally once daily). We
will compare ambulatory BP, the BP control rate, and patient adherence and acceptability to treatment
between the groups. Specific Aim 2 will test the hypothesis that chronic lower leg heat therapy will improve
nitric oxide bioavailability which can decrease sympathetic vasoconstriction and improve vascular function in
older hypertensive women. We will use state-of-the-art techniques of microneurography, Doppler ultrasound,
applanation tonometry, and cutaneous microdialysis to assess sympathetic neural control, indices of conduit
and resistance vessel vasodilator function, and interstitial metabolites (i.e. nitrate and nitrite) indicative of basal
nitric oxide bioavailability in all patients enrolled in Aim 1 before and after 8 weeks of heat therapy. Information
obtained from this research project will guide evidence-based clinical practice. It is anticipated that our study
may lead to revision of hypertension guidelines to incorporate home-based heat therapy as adjuvant to
antihypertensive drug(s) for older women, as well as other patient populations.

Public health relevance
PROJECT NARRATIVE Uncontrolled hypertension is a major risk factor for cardiovascular disease - the leading cause of death in the United States. Currently, over half of women older than 65 with hypertension have uncontrolled blood pressure despite being on standard drug treatment. Through this study, we aim to determine whether the combination of home-based lower leg heat therapy and a blood pressure medication is an effective treatment option for older hypertensive women; in addition, we will investigate the effects of heat therapy on neural and vascular health in these patients.